Native Alzheimer's Disease Resource Center for Minority Aging Research (NAD-RCMAR)

OVERALL ABSTRACT
American Indians/Alaska Natives (AI/ANs) and Native Hawaiians/Pacific Islanders (NHPIs) are increasingly
concerned about Alzheimer’s disease and related dementias (ADRD), as these conditions will have a major
impact on their communities. Although AI/ANs and NHPIs are culturally diverse and dispersed throughout the
US, they share a high prevalence of ADRD risk factors. In addition, life expectancies for AI/ANs and NHPIs have
improved over the last 50 years by as much as 30 years, resulting in a tripling of their population share of people
aged 65 and older. The confluence of perceived need, high risk, and limited data motivates us to propose a
Native Alzheimer’s Disease-related Resource Center in Minority Aging Research (NAD-RCMAR). Our research
team offers unique scientific resources and opportunities as well as an extensive network of academic and
community partnerships. Based at Washington State University (WSU), with collaborators at Stanford University
and the University of Colorado, we will create an innovative program to understand, intervene on, and mitigate
the ADRD-related health disparities experienced by AI/ANs and NHPIs. The Center’s theme will emphasize
AI/AN and NHPI health disparities and aging from the individual to the population level. Our Research Education
Component will fund meritorious Pilot Studies led by early-career investigators known as RCMAR Scientists.
RCMAR Scientists will receive mentorship and training in methods, measurements, and study designs that meet
high scientific standards and are culturally appropriate. They also will be mentored in the development of
successful funding proposals so that they can pursue independent careers in ADRD research. Notably, 13
professionals who are either AI/AN or NHPI will participate as Co-Investigators, Consultants, or RCMAR
Scientists. Our Specific Aims are to: 1) Build infrastructure, assemble resources, and provide scientific expertise
to enhance the diversity of the aging research workforce by mentoring promising junior and mid-level
underrepresented minority scientists for sustained careers in ADRD research, focusing on AI/AN and NHPI
populations; 2) Recruit RCMAR Scientists, especially those of AI/AN, NHPI, and other URM backgrounds, to
conduct Pilot Studies in the social, behavioral, epidemiological, and clinical sciences on ADRD, and use these
Pilot Studies as a vehicle for delivering mentorship and career guidance; and 3)Promote advances in ADRD
research and increase the number of independent underrepresented minority researchers, with an emphasis on
AI/AN and NHPI health faculty, who can address the health and well-being of AI/AN and NHPI elders, health
disparities, and aging from the individual to the societal level. NAD-RCMAR will also capitalize on the national
network of Satellite Centers created by Drs. Buchwald and Manson and led by AI/AN researchers. These Satellite
Centers will ensure that our efforts are national in scope, especially our recruitment of RCMAR Scientists, our
identification of datasets relevant to ADRD in AI/ANs and NHPIs, and our dissemination of results. This work will
help address NIA’s research priorities for ADRD among underrepresented minorities, as articulated in the 2012
National Plan to Address Alzheimer's Disease. Our Center responds to NIA’s interest in diversifying the scientific
workforce.

Public health relevance
OVERALL NARRATIVE We will launch an effort to describe, understand, intervene on, and mitigate the Alzheimer’s disease health disparities experienced by American Indians, Alaska Natives, Native Hawaiians, and Pacific Islanders. We will achieve this goal by funding social and behavioral Pilot Studies that advance the field, emphasizing the recruitment and mentorship of Native junior and mid-level researchers. These trainees will receive training on methods and analyses so that their work meets high scientific standards, while being culturally appropriate. This work will advance Alzheimer’s disease research and increase the number of independent investigators focused on Alzheimer’s disease disparities experienced by our target populations.